Early Career Cancer Clinical Investigator Award for Fiscal Year (FY) 2024

I am a radiation oncologist with significant training and expertise in clinical research, qualitative methodology,
and survey design. My research program focuses on the characterization and management of treatment-related
toxicities, with a focus on implementing patient-reported outcomes both in clinic and in trials. I collaborate closely
with multidisciplinary colleagues at my institution and beyond, aiming to incorporate patient voices through
optimizing the use to patient-reported outcomes to improve shared decision-making with cancer patients.
Planned activities supported by this award are designed to substantially increase my cooperative group
involvement and expertise in incorporating patient-reported outcomes into large prospective clinical trials.

Public health relevance
The proposed activities will enhance the incorporation of patient-reported outcomes into national clinical trials, both through supporting the incorporation of patient-reported outcomes in protocols in development and through the development of my own trial concept through ECOG-ACRIN’s Cancer Care Delivery Research Committee. This work will increase our ability to include patient voices into the interpretation of clinical trials, improving our ability to engage in shared decision-making with cancer patients.